OBSTETRICAL SONOGRAPHIC DATA BASE

CDMAS only. The aim of the sonographic database protocol is to develop and establish a database of fetal sonographic measurement and findings that will be used for clinical care and research purposes. Sonographic databases have been used successfully to establish normograms for fetal biometric parameters and to establish level of risk for sonographic findings associated with fetal trisomies. Outcome prediction based on sonographic findings can also be addressed. Data generated at Washington University suggested that fetal hydronephrosis could be detected and the severity predicted by sonographic measurements of fetal renal pelvis. Refinement of the normograms of the fetal renal pelvis and establishment of the sensitivity of ultrasound in the detection of hydronephrosis are areas of future research. The spread sheet application will be used to compare values to normograms and compute circumferences, ratios and estimation of fetal weight.